Lysosomal dysregulation contributes to HAND

SUMMARY
The lysosomal function is essential for protecting neuronal homeostasis. A precise lysosome activity and
dynamics are crucial to maintaining the degradation of lipids, misfolded proteins, and damaged organelles.
Undigested products from the lysosome are neurotoxic and responsible for neurodegenerative diseases.
Lysosomal dysfunction can lead to the aggregation of alpha-synuclein (-Syn), associated with cognitive,
speech, and movement disorders often observed in patients suffering from Parkinson's disease. Clinical studies
also showed that a significant number of HIV-1 infected patients suffer from neurological disorders, including
cognitive, speech, and motor disorders that affect their gait and body agility, like parkinsonian-like symptoms or
Parkinsonism. However, the mechanisms involved remain unclear. Our goal is to characterize how HIV-1
decreases neuronal clearance leading to a progression of HIV-associated neurocognitive disorders like motor
dysfunction. We showed that HIV-1 Vpr protein: (i) triggers the accumulation of -Syn in neurons after decreasing
the lysosomal acidification; (ii) disrupts the organelles trafficking by provoking the loss of microtubules activity;
and (iii) deregulates the lysosome movement and positioning. Proteomic analysis showed deregulation in the
expression levels of several proteins involved in lysosomal maturation in Vpr-treated neurons. Among these is
the SNAPIN protein that regulates lysosomal acidification, positioning, and trafficking in neurons. Therefore,
using neuronal cells, iPSCs, and an animal model, we propose to determine the post-translational regulation of
SNAPIN in its environment and by HIV-1 Vpr (Aim 1). Since the transport of lysosomes into the axon is necessary
for efficient degradation, we will explore the impact of Vpr-induced SNAPIN dysregulation on lysosomal transport
(Aim 2). Finally, lysosomal degradation is an essential part of protein homeostasis; we will use a multi-omics
approach to identify pre-clinical markers (that aim to restore SNAPIN and lysosomal functions) in the presence
and absence of Vpr and SNAPIN and assess the metabolic disturbances underlying neurological impairment
resulting in long-term neurological outcomes (Aim 3). This study will bring a better understanding of the general
regulation of the autophagic clearance by HIV-1 Vpr and SNAPIN and highlight how lysosomes are reshaped
during HIV-1 infection and affect different longevity-promoting pathways.

Public health relevance
NARRATIVE This application aims to understand the increasing incidence of movement disorders or parkinsonism in HIV- infected patients. We demonstrated that Vpr protein causes these damages through SNAPIN and lysosome de- acidification. We will i- identify the mechanisms used by Vpr to deregulate SNAPIN, ii- the effect of this deregulation on SNAPIN functions and binding, and iii-use an advanced approach to determine if other proteins are involved so SNAPIN function can be restored.